An Immunological investigation of Meniere's disease

Project Summary/Abstract
In this proposal we hope to build on our efforts showing innate and adaptive immune cell infiltration of
labyrinthine tissue in Meniere’s disease. These findings have led us to propose an autoimmune basis for
the disease. Our efforts will be directed at confirming our preliminary data that specific pathways
including druggable TNF alpha and mTOR pathways are upregulated in Meniere’s disease and establishing
that labyrinth infiltrating B cells are autoreactive. We hope that our work will lead to better understanding
and rational therapeutics of this poorly understood disease.

Public health relevance
Project Narrative: Meniere’s disease a disabling disorder that shows a sharp age dependence causing dizziness and hearing loss has a poor biological understanding. Based on our findings of B and T cell infiltration of labyrinthine tissue obtained at post-mortem from Meniere’s patients, and on our single cell RNA sequencing demonstrating innate and adaptive immune cell infiltration of labyrinths from patients with Meniere’s disease, we propose that it has a component of autoimmunity. In this grant application, we propose to use cutting edge technologies including single cell RNA sequencing and single cell B cell receptor sequencing to identify autoantibodies of labyrinthine tissue to investigate an autoimmune basis for Meniere’s disease.